Effects of Surgical Removal of Uterine Fibroids on Atherosclerotic Cardiovascular Disease

PROJECT SUMMARY
Atherosclerotic cardiovascular disease (ASCVD) is the leading cause of morbidity and mortality among females
in the US, although nearly 80% of events are preventable. Identifying reproductive aged females at high-risk of
ASCVD whom early prevention may benefit is crucial to reduce the national burden of disease. Uterine fibroids
have been linked to an increased risk of ASCVD due to systemic inflammation and plaque formation. However,
whether treatment for uterine fibroids impacts said risk has yet to be studied using rigorous epidemiologic
methods, including the use of large, real-world datasets with long-term follow-up and causal inference methods.
Concerningly, the most common surgical treatments for uterine fibroids, specifically hysterectomy and
myomectomy, may affect risk of ASCVD. Undergoing a hysterectomy during reproductive-aged years may lead
to early onset of menopause and increased risk of ASCVD due to the early cessation of estrogen's ASCVD
protection, yet this has not been examined explicitly among a cohort of pre-menopausal females with uterine
fibroids. No data exists on the long-term cardiovascular effects of myomectomy. The goal of this proposal is to
apply methodologically rigorous designs and leverage large-scale administrative claims to address knowledge
gaps regarding real-world ASCVD events associated with uterine fibroids and respective surgical management.
In Aim 1, we will estimate the effect of surgical management for uterine fibroids on risk of ASCVD using a novel
sequential target trial emulation approach. Target trial emulation avoids biases that are common flaws in
observational studies by articulating the causal question of interest in the form of a hypothetical randomized trial
and explicitly emulating each component of such trial using observational data. Given the methodological
challenge that few individuals will undergo surgical management during a prespecified eligibility period, we will
emulate a series of trials with short enrollment periods applying g-methods used to address changing surgical
strategies over time. Overall, the proposed research will contribute to efforts in improving long-term health among
females and promoting gynecological health for lifelong wellness. It will also provide crucial support in enabling
an exceptional research trainee to prepare for a career as an academic investigator focusing on applying causal
inference methods to reproductive and cardiovascular epidemiology.

Public health relevance
PROJECT NARRATIVE Data have demonstrated that uterine fibroids are risk-enhancing conditions for atherosclerotic cardiovascular disease (ASCVD) among reproductive-aged females, yet the impact of surgical removal of fibroids is unknown. The goal of the proposed research is to evaluate the impact of surgical removal of uterine fibroids, specifically hysterectomy and myomectomy, on ASCVD among reproductive-aged females. The results of this work will address a dearth of data on long-term health impacts of uterine fibroids and help inform clinician counseling practices to reduce the national burden of ASCVD going forward.